Admin Core

The administrative core will provide cohesiveness and scientific leadership to the program project
grant, cultivate an environment that maximizes collaborative research, encourage collaboration
across all joint Program Project groups, promote, monitor and facilitate effective communication
and rapid dissemination of information to accelerate progress of the scientific aims of the PPG,
and execute administrative oversight of the grant. In addition, it will manage all relevant
organizational and logistical components for successful administration of the P01, and provide
fiscal oversight for the program project grant such as appropriate allocation and accurate
accounting of funds and execution of the subcontracts, review of expenditures, as well as
assistance in preparation of PPG-related documents. Finally, the administrative core will perform
frequent review of scientific progress, guarantee its compatibility with the overall aims of the PPG,
and ensure that all the research performed with financial support from the PPG and all financial
expenses are in full compliance with all institutional, governmental, and NIH regulations and
policies.

Public health relevance
The administrative core ensures the successful administration of the PPG by providing: (1) leadership, oversight and cohesiveness, (2) communication and dissemination of information for maximal interdisciplinary collaborative research, and (3) management and fiscal oversight. In addition, the administrative core guarantees that the PPG meets its overall goals and complies with all institutional, governmental, and NIH regulations and policies.